Pretargeted Radioimmunotherapy of CD20+ Lymphomas

DESCRIPTION (provided by applicant): Preliminary clinical trials have demonstrated that radiolabeled anti-CD20 monoclonal antibodies can achieve remissions in 65-90% of lymphoma patients failing chemotherapy. However, most patients treated with conventional radiolabeled antibodies (RAb) subsequently relapse and die of recurrent lymphoma. The objective of this research proposal is to optimize radioimmunotherapy (RIT) of B cell lymphomas utilizing pretargeting amplification strategies to improve the efficacy and decrease the toxicity of conventional RIT. Two separate pretargeting approaches will be investigated, one using streptavidin (SA) and radioactive biotin and the second employing molecularly engineered bispecific anti-CD20 x anti-ligand antibodies which bind covalently to radiolabeled ligands. First, we will compare the in vivo biodistribution, radiation dosimetry, and therapeutic efficacy of pretargeted ß-emitting radionuclides (90Y, 177Lu) with pretargeted α-emitters (213Bi, 211At) and with conventional RIT in murine xenograft models. Second, we will employ novel new digital autoradiographic methods to perform small scale microdosimetry of alpha-emitters deposited in tumor micro- clusters and xenografts with either conventional RIT or pretargeted RIT (PRIT) and correlate these findings with observed tumor eradication rates. Third, we will evaluate the pharmacokinetics, biodistributions, toxicities and efficacies of novel, molecularly designed bispecific anti-CD20 x anti-ligand Abs which possesses a molecularly engineered binding pocket capable of binding covalently to synthetic radiolabeled electrophilic ligands. These bispecific anti-CD20 x anti-ligand Abs will be compared directly to the SA-biotin pretargeting approach in lymphoma models. Finally, we will investigate potential synergy of novel new small molecule inhibitors of Bruton tyrosine kinase (ibrutinib), PI3 kinase-delta (idelalisib), and BH3-mimetics (ABT-199) with PRIT using both α and ß emitters. We hypothesize that the pretargeting strategies defined in this proposal will improve the tumor-to-normal organ ratios of absorbed radiation compared with conventional RIT, allowing improvement in response rates and response durations with less toxicity than is currently feasible. We hypothesize that pretargeting will eliminate the necessity of administering myeloablative doses of 131I- or 90Y- labeled anti-CD20 Ab with hematopoietic stem cell rescue to achieve maximal response rates and survival rates. We anticipate rapid translation of the results of these preclinical experiments into our clinical RIT program for human Non-Hodgkin's lymphomas.

Public health relevance
PUBLIC HEALTH RELEVANCE: Approximately 75,000 Americans are expected to develop Non-Hodgkin Lymphoma in 2014 and less than half will be cured with conventional treatments. Radiolabeled monoclonal antibodies targeting the CD20 antigen expressed on the surface of most lymphomas are effective at inducing remissions even after failure of standard chemotherapy and radiotherapy. This grant proposal describes the development of several innovations that markedly improve the effectiveness and decrease the toxicity of radiolabeled antibody therapy for lymphomas.